Discovery and characterization of programmable biological systems

Abstract
The natural world is filled with fascinating proteins and the arms race between bacteria and
viruses is a particularly rich reservoir for their discovery. Research in this area over the past decades
has uncovered restriction enzymes for genetic mapping, T7 phage polymerase used in the
production of mRNA vaccines, and Cas9 for genome editing, and motivates continued exploration
into this genetic conflict for useful molecular machines. Bacteria have many defense strategies
against foreign elements, including CRISPR-Cas systems, which typically provide immunity through
RNA-guided nuclease activity, however, my work has uncovered new RNA-guided functions
including CRISPR-associated transposases that perform RNA-targeted DNA insertion, and CRISPR-
associated proteases that cleave protein substrates upon target RNA detection. These systems
reveal exciting new biology and how diverse enzymes can acquire, or be acquired by, RNA-guided
proteins and I believe only scratch the surface of programmable functions that exist in nature.
Practically, the characterization of new RNA-guided functions will enable new capabilities in
biology to alter and control cells based on genetic information. The discovery of Cas9 and
programmable nucleases opened the door for genome editing technology and I envision that
additional programmable modalities could similarly transform biology and provide much needed
molecular tools to interrogate the function and regulation of the human genome. Advances in DNA
and RNA sequencing have provided insight into gene function, mutations that cause disease, and
unique cell populations based on gene expression signatures, however, we lack the ability to alter
and control cells based on their genomic and transcriptomic state. My goal is to discover and
characterize proteins that are regulated via nucleic acid recognition and to harness these
discoveries to engineer and control human cells.

Public health relevance
Narrative The natural world is filled with fascinating proteins and the arms race between bacteria and viruses is a particularly rich reservoir for their discovery. This proposal investigates how cells sense and respond to foreign nucleic acids, what other RNA-guided functions exist in nature, and how these might be harnessed to control human cells based on their nucleic acid information.